IGF::OT::IGF TASK ORDER 34: PSYCHOLOGY AND POPULATION-LEVEL CANCER CONTROL STRATEGIES WORKSHOP INTENSIVE: LOGISTICS SUPPORT

The Basic Biobehavioral and Psychological Sciences Branch (BBPSB), within the Behavioral Research Program (BRP), Division of Cancer Control and Population Sciences, National Cancer Institute (NCI) has the following program support needs related to the NCI Psychology and Population-Level Cancer Control Strategies Workshop Intensive which is scheduled to take place from May 16-18, 2016, to be held at the Bolger Center in Potomac, Maryland. Approximately 50 people (25 sponsored non-federal invited experts/speakers and 25 federal experts) will participate in the workshop intensive